Administrative Core

PROJECT SUMMARY: Administrative Core
The Iowa Superfund Research Program (ISRP) is a highly integrated research center focusing on the sources,
exposures, toxicities, and remediation of polychlorinated biphenyl (PCBs) congeners in air. The center’s
integration across biomedical and environmental science and engineering disciplines requires organizational
infrastructure to enable the frequent, regular exchange of ideas, experiments, and data among projects and
cores. The Admin’s Core’s major goal is to maintain a structure that promotes research integration, enables
timely communication, and supports research translation that raises the quality and impact of center activities.
The Admin Core provides vision and direction to ensure continued success in research and stakeholder
engagement. To meet this goal, the Admin Core has three aims: 1) Provide program leadership and
infrastructure to ensure synthesis of findings and integration of activities. Director Hornbuckle and Deputy
Director Lehmler are leading environmental health researchers with backgrounds in environmental engineering
and biomedical science, respectively. The ISRP Executive Committee, composed of leaders from every
program component and representing diverse disciplines, works with Hornbuckle and Lehmler to ensure full
integration and coordination among projects and cores. The leadership actively promotes frequent and regular
researcher interactions both inside and outside the ISRP through monthly meetings, seminars, and events.
The Admin Core conducts annual assessments of productivity and effectiveness for each project and core to
guide recommendations from the External Advisory Committee (EAC), which is composed of nationally
recognized Superfund researchers and other stakeholders. 2) Provide administrative and fiscal services,
support, and oversight to ensure robust stewardship of available resources. The Director, together with the
Center Administrator and Fiscal Manager, provide programmatic and financial services, support, and oversight.
The ISRP is housed under and supported by IIHR—Hydroscience & Engineering, which has extensive
experience managing multidisciplinary, multi-institutional projects ranging from thousands to tens of millions of
dollars. 3) Disseminate ISRP scientific and environmental health discoveries through effective research
translation. The ISRP is dedicated to making center research available and accessible in consideration of the
SRP research translation objectives: a) communication with SRP and SRP staff; b) partnerships with
government agencies; c) technology transfer; and d) information dissemination to other end-users, with a
particular focus on communicating in the manner most appropriate for each audience. If the ISRP is renewed,
regular activities will include the biennial International PCB Workshop; social media news feeds; webinars and
training workshops; decision-support tools for agencies and organizations managing PCBs in schools; web
applications to disseminate research findings; and development of new technology and platforms to maximize
bi-directional communication.

Public health relevance
PROJECT NARRATIVE: Administrative Core The major goal of the Iowa Superfund Research Program Administrative Core is to maintain a structure that: 1) promotes integration of research; 2) enables timely communication and research translation that raises the quality and impact of center activities; and 3) provides vision and direction to ensure the center’s continued success in conducting outstanding research stakeholder engagement. The Administrative Core provides administrative and fiscal services, support, and oversight to ensure robust stewardship of available resources.